Mechanisms of Corneal Neuro-Immune Crosstalk

Summary
The long-term goal of the proposed project is to find a novel diagnostic and treatment
approaches that address the corneal hypoesthesia, the hallmark of the neurotrophic keratitis
(NK), a vision-threatening condition that results from injury or dysfunction of corneal nerves
and subsequent corneal sensory nerve degeneration. The objective of this proposal is to
determine the immune cell-type-specific ligand-receptor pairs that are involved in
bidirectional cross talk between resident corneal immune cells and sensory afferent nerves
originating from the neurons of trigeminal ganglia, and how these interactions impact the
sensory afferents in the neurotrophic keratitis (NK). The central hypothesis is that subsets of
immune as well as non-immune corneal cell populations play a crucial role in regulating
survival and regenerative capacity of corneal sensory afferent neurons via direct neurotrophic
support in healthy corneas and that the lack of these neurotrophic factors exacerbate
degeneration of TG-derived sensory afferents resulting in progression of NK. The rationale
underlying this proposal is that while corneal sensory nerves were shown to promote
epithelial and stromal health through secretion of neurotrophic factors and neuropeptides, the
target cells, including corneal parenchymal cells and resident and infiltrating leukocytes,
also can produce biologically active neurotrophic factors that maintain corneal nerve
survival, regeneration and importantly, can impact course of neurodegeneration. The central
hypothesis will be tested by pursuing three specific aims: 1) To characterize the cell populations
and molecular pathways involved in NK; 2) To identify corneal modulators of diseased nerve
function/degeneration in TG-derived sensory afferents in vitro; 3) To assess the role of
immune cells in the loss of corneal nerve function/degeneration in NK in vivo. We will pursue our
goal using both recently-developed techniques specific to state-of-the art gene expression
analysis, the next-generation protein expression analysis, intravital multiphoton microscopy,
corneal electrophysiology and more-established techniques that have been uniquely and
successfully applied in our laboratory. The expected outcome of this work is a deeper
understanding of which neurotrophic molecules and corneal cell populations contribute the most
to the positive clinical outcome in the NK. The results will have an important positive impact
immediately because they will establish better understanding of complexity of the neuro-immune
crosstalk, and long-term because they lay the groundwork to develop cellular-based therapies to
promote corneal nerve regeneration for better treatment of NK.

Public health relevance
Project Narrative We propose to investigate the role of the corneal parenchymal and resident immune cells in the bidirectional crosstalk with the nerve system in neurotrophic keratitis. This project is focused on discovery of the bioactive neurotrophic factors that are potentially synthesized by corneal cells to maintain corneal integrity and neuronal homeostasis, and are capable of modulating function and regenerative capacity of the corneal sensory nerves in neurotrophic keratitis.